Modeling neurofibromatosis-1 disease heterogeneity to optimize risk assessment and treatment

Project Summary
As we envision employing personalized approaches in medical practice, it is important to define the genomic,
cellular, and molecular etiologies that underlie disease pathogenesis and determine how these determinants
are modified by intrinsic and extrinsic influences (risk factors). This challenge is nicely illustrated by
Neurofibromatosis type 1 (NF1), a rare neurogenetic condition caused by germline mutations in the NF1 gene.
The hallmark of NF1 is extreme clinical heterogeneity, where children are prone to the development of a wide
variety of neurological problems, including cognitive and behavioral problems (neurodevelopmental deficits;
NDDs) and low-grade brain tumors (low-grade gliomas; LGGs). While making the diagnosis of NF1 in a child is
usually straightforward, it is currently not possible to predict what medical problems will develop in any given
child, how their disease will progress, and what therapies will be most effective. Moreover, our current
therapies are effective for only a subset of patients, exhibit variable non-sustained responses, and sometimes
result in accelerated growth following treatment cessation. We theorize that these disappointing outcomes
reflect the use of a reductionist approach, in which a single cell type (e.g., neuron, cancer cell) or signaling
pathway (e.g., MEK or mTOR activation) is targeted, largely ignoring the fact that these medical features result
from the interactions of numerous distinct cell types (e.g., tumor cells, neurons, T cells, microglia) each with
unique signaling pathway dependencies and tissue-level cellular and molecular interdependencies. Based on
observations made possible by the flexibility of our prior R35 Research Program Award (RPA), we now
hypothesize that these medical problems should be conceptualized as systems biology abnormalities in which
risk factors (disease modifiers) converge on the specific multicellular circuits that drive and maintain these
clinical phenotypes. For this new RPA, we propose to deploy a more holistic and integrated approach to
elucidate the multicellular circuits that underlie the development and progression of NF1-associated LGG and
NDD, the two most common nervous system problems in children with NF1. Leveraging patient-derived and
CRISPR-engineered human iPSCs, patient-derived primary LGG cell lines, mice with patient-derived germline
NF1 gene mutations, cell type-specific Nf1 conditional knockout strains, and multi-omic bioinformatic analysis
approaches, we aim to (1) mechanistically define the cellular and molecular interdependences that underlie
NF1 LGG and NDD pathobiology and (2) determine how these multicellular circuits are modified by risk factors
to create the clinical heterogeneity that characterizes NF1. The overall mission of this project is to establish the
etiologic bases for NF1 clinical variability and create a blueprint for other similar neurogenetic disorders
affecting children and adults.

Public health relevance
Narrative The implementation of precision medicine approaches for rare neurogenetic disorders, like neurofibromatosis type 1 (NF1), requires that we define the etiologic causes for NF1 clinical phenotypes and determine how they are modified by intrinsic and extrinsic influences (risk factors). This proposed Research Program Award aims to elucidate the circuit-level causative mechanisms that underlie the development and progression of brain tumors and neurobehavioral abnormalities in children with NF1. The inherent flexibility of the R35 mechanism will enable us to leverage novel laboratory-generated Nf1 mouse strains and human iPSC lines to identify the responsible cellular and molecular circuit-level interdependencies critical to the design of future transformative therapies and risk assessment strategies.